Alternative splicing in the mouse inner ear at single cell resolution

Sensorineural hearing loss and vestibular dysfunction are common sensory disorders affecting
millions of
individuals worldwide¹,². The primary cause of both hearing loss and peripheral vestibular
disorders in humans is dysfunction of the inner ear, which can occur as a result of noise exposure,
aging, genetic defects, environmental exposure to pathogens, and as a side effect of ototoxic
medications. There are limited therapies for sensorineural hearing loss and vestibular dysfunction,
mainly due to the lack of understanding of some of the molecular mechanisms that govern the hearing
and balance organs. There remain key unanswered questions about the genetic architecture and
molecular mechanisms of transcriptional control used during mammalian development and within the
adult inner ear. Recently, single cell RNA sequencing technology has shown the remarkable
transcriptional heterogeneity of cell types and developmental dynamics of the mouse inner ear³??.
However, transcriptional diversity and control is only one level of genetic regulation. One of the
key underlying mechanisms of transcriptomic and protein diversity is through alternative splicing.
Cells use alternative splicing to diversify their number of proteins, change translation
efficiency, control transcript localization, and make non-coding RNAs?,?. Only a limited number of
genes that undergo alternative splicing have been identified in the inner ear at cell type
resolution?. Understanding alternative splicing of genes at the single cell level is critically
important as any future therapies targeting a specific gene may have on/off target effects in
different subsets of cells. We hypothesize that there is cell type-specific diversity of
alternatively spliced mRNA within the mammalian inner ear. Moreover, regulation of alternative
splicing events occurs through specific RNA binding proteins (RBPs). We will test this hypothesis
through two aims: Aim 1 is to characterize the transcriptome-wide alternative splicing landscape of
the mouse inner ear at single cell resolution. Using newly developed computational tools, we will
identify alternatively spliced genes within both the developing and adult mouse inner ear for the
entire transcriptome. Aim 2 will determine the role of RNA binding proteins in regulating
alternative splicing programs in the inner ear at single cell resolution. Regulation of alternative
splicing events is a key post-transcriptional mechanism that cells use to determine what splicing
program mRNA goes through as carried out by RNA binding proteins. We will characterize the
expression of RBPs within the developing mouse inner ear and link this to alternative splicing
through computational and validation techniques to develop a spatial and temporal map of
alternative splicing programs. In sum, we will define the heterogeneity of cell types based on
single cell isoform-level data during development and in the adult mammalian inner ear, and we will
identify the key players in regulating alternative splicing. This work will
d alternative splicing regulation during development and in
the adult inner ear that will be necessary for future development of targeted inner ear therapies.

Public health relevance
PROJECT NARRATIVE Hearing loss and balance problems affect millions of people world-wide and are most commonly caused by loss of specialized cells called hair cells, which are small mechanical sensors that send information about hearing and balance to the brain. In this project, we use mouse tissues to understand the different types of RNA that cells from the inner ear organs make. We will look to see how different types of RNA shape these organs in young and adult mice to ultimately learn how to treat hearing and balance disorders in the future.